Protocal Specific Research Support

I. Purpose The purpose of Protocol Specific Research Support (PSRS) is to help maintain conduct of high priority, innovative, feasibility and phase I clinical research protocols at the Mayo Clinic Cancer Center (MCCC), regardless of Mayo campus.